Admin Suppl Gender-affirming estrogen therapy and breast cancer treatment outcome

Project Summary
Our parent R21 grant (R21 CA267088) was to understand transfeminine patients’ risks and
benefits of continuing gender-affirming estrogen therapy (ET) during their breast cancer (BC)
treatment. Transfeminine individuals are assigned male at birth and most pursue ET to affirm their
feminine identity. As the transgender population increases, there will be a substantial number of
transgender individuals at risk for cancer as they age within the next 20 to 50 years. For
transfeminine patients diagnosed with BC, there is no clinical guideline whether they can continue
receiving ET during BC treatment, and whether ET affects their BC prognosis. The
discontinuation of gender-affirming hormones for a transgender individual is undesirable as it
greatly affects their emotional well-being and body image, and compounds their cancer-induced
emotional distress. In order to address the clinical question of the risks and benefits of
transfeminine patients continuing ET during BC treatment, the overall strategy of our parent R21
was to use three mouse models of BC—Pik3camut, Brca1mut, or Tp53mut—to understand the
effect of ET on BC treatment outcomes. We will compare tumor growth rates, breast histology,
and treatment outcomes between male mice that continue and discontinue ET during BC
treatment with alpelisib (for Pik3camut tumors), olaparib (for Brca mut tumors), or eribulin (for
Tp53mut tumors). In Year 1, we completed the experiments for Brca1mut tumors and olaparib
treatment. For the first half of Year 2, we will focus on completing experiments for Tp53mut
tumors to complement our Brca1mut findings. This will allow us to obtain a general overview of
how ET affects estrogen receptor negative (ER-) BC treatment. This supplement proposes three
additional molecular assays to explain our findings for Brca1mut and Tp53mut tumor models: 1) to
measure olaparib/eribulin levels in the tumors using mass spectrometry; 2) to profile ER- tumors
using RNASeq to identify gender and sex-hormone related molecular mechanisms influencing
BC treatment outcomes; and 3) assess the effect of gender and/or sex-hormone on tumor
immune contexture using multiplex immunofluorescence staining. Collectively, our work will
have direct and immediate clinical translation to inform ER- BC treatment options and decisions
for the transfeminine community. Our findings will also inform us why BC occurring in males are
more aggressive than in females, thus improving treatment strategies for cisgender men and
women with BC as well.

Public health relevance
Project Narrative As the transgender population increases, there will be a substantial number of transgender individuals at risk for cancer as they age within the next 20 to 50 years. The medical community needs to be ready with knowledge and clinical guidelines to manage their cancer treatment. Towards that goal, we utilize established mouse models of estrogen receptor positive and negative breast cancers to study the effect of gender-affirming estrogen treatment on breast cancer treatment outcome.